The Louisiana Clinical Center of Nutrition for Precision Health (LA-NPH)

PROJECT SUMMARY
Nutrition is at the epicenter of human health and disease. However, our current “one size fits all” approach to
clinical nutrition is failing a large segment of the population. Individual factors including genetics, metabolism,
physiology, microbiome, behavior, the built in and contextual environment all underlie the inherent variability in
response to diets. Exciting new research shows that machine learning algorithms can integrate this complex
information and predict how someone responds to a given diet. If validated, this innovative approach will
provide a radical change in the delivery of personalized nutrition prescriptions to promote health and treat
chronic diseases. The goal of the “Nutrition for Precision Health (NPH), powered by All of Us” consortium is to
generate a rich database from a diverse population to develop a first-of-its-kind diet prediction algorithm. The
aim of the Louisiana-Arizona Nutrition for Precision Health Center (LAAZ-NPH), consisting of LSU-Pennington
Biomedical (PBRC) in Baton Rouge, LSU-Health Sciences Center (LSUHSC) in New Orleans, and the NIDDK-
Phoenix Clinical Center (PIMC) in Phoenix, is to participate in the NPH consortium as a clinical center to
recruit, enroll and retain more than 2000 participants in the three planned study modules. In Module 1, 2,000
from the All of Us Research Program in Louisiana (Baton Rouge and New Orleans; 600 each) and Arizona
(Phoenix; 800) will be enrolled in a 10-day prospective, observational study. Following the completion of
Module 1, 300 study participants who meet specified eligibility criteria for enrollment to the controlled feeding
studies, will participate in Module 2 (PBRC, LSUHSC and PIMC; 100 each) and at least 100 in Module 3
(PBRC and PIMC only; ≥50 each). Module 2 is a controlled feeding study in an outpatient setting with 300
study participants while Module 3 is a controlled feeding study in an inpatient setting with at least 100 study
participants that completed Module 1. Modules 2 and 3 will use a block randomization cross-over study design
to evaluate the individual response to three, 14-day isocaloric diet interventions. The three intervention diets (a
combination of the Mediterranean and DASH diet (MEDASH); a sustainable predominantly plant-based
Flexitarian diet (FLEX) and a Highly Preferred Western Diet (HPWD) will be separated by a 7-21 day wash out
periods. Our primary endpoint is the post-prandial plasma glucose response (PPGR) to a standardized mixed
meal tolerance test (MMTT) as measured by the incremental glucose area under the curve over 180 min
(AUC180). Secondary endpoints are biomarkers of cardiometabolic health including insulin resistance and a
metabolic syndrome score. The rich set of data and biospecimens collected by our proposed center will be
used to inform paradigm shifting approaches that enable large-scale delivery of personalized dietary
prescriptions to promote general health, delay cardiometabolic diseases, and importantly address health
disparities.

Public health relevance
PROJECT NARRATIVE The Louisiana-Arizona Nutrition for Precision Health Center (LAAZ-NPH), consisting of LSU-Pennington Biomedical in Baton Rouge, LSU-Health Sciences Center in New Orleans, and the NIDDK-Clinical Center in Phoenix aims to recruit participants from the All of Us research program into the three proposed modules of the NPH consortium with an emphasis on minorities, including African American, Hispanic, and Native American populations. In Module 1 (n=2,000), we will carefully catalogue habitual dietary intake and measure the post- prandial glucose response (PPGR) to a standard mixed meal tolerance test (MMTT) and collect baseline measures of health, behavior and environment. The same MMTT will be used to compare the PPGR and inter- individual variability to three distinct eucaloric diets, each eaten for 2-weeks in a crossover randomized order: a hybrid Mediterranean-DASH diet (MEDASH); the sustainable and predominantly plant-based Flexitarian diet (FLEX); and the ubiquitously available Highly Preferred Western Diet (HPWD) to both free-living (Module 2, n=300) and domiciled (Module 3, n≥100) individuals.